Using Ecological Momentary Assessment to Examine Relationships Between Emotional Responding, Craving, and Substance Use, in Veterans with Posttraumatic Stress Disorder

Comorbid Posttraumatic Stress Disorder and Substance Use Disorder (PTSD-SUD) affects
approximately one-third of Veterans. PTSD-SUD is associated with a host of deleterious outcomes including
more severe symptoms, higher suicidality, and worse treatment outcomes. Thus, in order to improve
healthcare for these high-risk Veterans, there is a critical need to better understand the mechanisms
underlying PTSD-SUD. Both theoretical and empirical work suggest emotional responding, the intensity and
duration of an emotional response to a trauma reminder, is one such mechanism. [For example, more intense
and prolonged emotional responding predicts stronger cravings for substance use even when controlling for
general negative affect. Thus, emotional responding appears to create a unique context for increased risk of
substance use beyond general negative affectivity.] Adaptive mobile health interventions could be developed
to target emotional responding and designed to deliver intervention to an individual in the moments of greatest
risk for substance use. However, more work is needed to inform intervention development. Importantly,
examinations of emotional responding have primarily been laboratory-based and have not examined the
relationships between emotional responding and actual substance use. Thus, a critical expansion of this work
will be to examine these dynamic relationships as they naturally unfold in the real world. Ecological momentary
assessment (EMA) is an ideal methodological strategy to capture these time-varying relationships because it
collects intensive longitudinal data (ILD) from individuals about their experiences throughout the day in real
world contexts. The proposed Clinical Sciences Research and Development CDA-2 aims to examine
mechanisms of PTSD-SUD using EMA. [This study has three primary aims: (1) test a hypothesized risk model
of the relationships between emotional responding, craving, and substance use, (2) examine a predictive
model of emotional responding and several other time-varying factors (e.g., distress tolerance, emotion
regulation, and substance use motives) on substance use, and (3) gather qualitative research partner input to
inform the development of a future adaptive mobile health intervention.]
The study will recruit 125 Veterans to reach our final sample of 110. Participants will include Veterans
with current PTSD-SUD and past month substance use. First, participants will complete a baseline research
visit to assess eligibility. Eligible participants will complete an orientation in EMA using a VA-developed EMA
app called mPRO. Next, they will complete a 30-day period of EMA. Participants will be asked to complete 4
EMA surveys each day: an initial survey and 3 pseudorandom signal-contingent surveys. Participants also
have the option to self-initiate an event-contingent survey at any time if they experience a trauma reminder. At
the end of weeks 1, 2, and 3, they will complete a short check-in visit. At the end of the EMA-monitoring period,
participants will complete a follow up visit, which includes a feedback interview focused on gathering research
partner input from Veterans and VA clinicians about their opinions and priorities for an adaptive mobile health
intervention. Results from this CDA-2 will guide the development of a future adaptive mobile health intervention
for Veterans with PTSD-SUD as part of a VA merit award. [By using ILD to better understand momentary
mechanisms of PTSD-SUD, future interventions can target the factors that are most predictive of risk for
substance use and provide greater access to more personalized approaches to healthcare.]
In addition to the research aims, this CDA-2 will provide the applicant with focused training in advanced
statistical methods for ILD, adaptive mobile health assessment and intervention (mHealth), the design and
conduct of clinical trials, and professional development and grantsmanship. This training will be essential to
facilitate the applicant’s transition to an independent VA clinical scientist with a career focused on developing
and testing adaptive mobile health interventions to improve healthcare for Veterans with PTSD-SUD.

Public health relevance
Approximately one-third of Veterans with PTSD also struggle with alcohol or drug use (PTSD-SUD), and this contributes to more severe symptoms, higher risk for suicide, and greater disability and life impairment. Further, PTSD-SUD makes it more challenging to engage with existing treatment approaches, which often are not able to provide support in the moments when risk for substance use is highest. Mobile health interventions have the ability to expand access to effective treatments and improve healthcare for Veterans with PTSD-SUD. This CDA-2 seeks to inform the development of a future mobile health intervention for Veterans with PTSD- SUD. In line with a precision medicine approach, results will identify factors that increase risk for substance use so that interventions can be better tailored to Veteran needs. This study will also seek input from Veterans to ensure that intervention development is Veteran-centered.